Biostatistics Core

CORE C: Biostatistics/Bioinformatics Core
PROJECT SUMMARY/ABSTRACT
The Biostatistics and Bioinformatics Core (Core C) provides support to the 3 primary projects, and Career
Enhancement and Developmental Research projects of the Prostate Cancer SPORE in the areas of study
design, data collection and visualization, database development and management, data quality control, data
analysis, clinical trial monitoring, bioinformatics, and interpretation. In this regard, members of the Core play an
integral role as members of the team for each project, and provide solutions to commonplace and complex or
unique problems that arise during the planning and execution of the projects. Each project has a primary
biostatistician/epidemiologist thoroughly versed in the subject matter associated with the project. Core
members also interact on a regular basis, and work closely with the Administrative (Core A) and Pathology
(Core B) Cores, which contributes to interactions and synergy among the projects. Core investigators have
extensive experience in a wide range of biostatistical, bioinformatics, epidemiologic and translational research
methodologies and applications, and have also developed novel methods, some of which will be used in this
SPORE. Because of the emphasis on translational science in the SPORE program, the Core also includes
members with experience in both epidemiology and biostatistics, who provide important input for translating
basic science to clinical trials and population cohorts.